Administrative Core

The role of the Administrative Core is to enable and facilitate the goals and specific aims already defined in the Overall Description section of this application. Therefore, the GOALS and SPECIFIC AIMS of this Core are the same as those stated in the Overall Description: 1) To develop a team of NIH ROl-funded investigators with shared research interests who will be competitive for Program Project and Center Grants. 2) To develop and improve critical infrastructure, and establish high expectations for productivity and success in research in biomedical sciences at MSU. This will be accomplished by achieving the following Specific Aims: 1. Develop an administrative core to recruit and mentor outstanding new investigators with commonality of research interest and expertise and develop effective long-term teams. 2. Coordinate mentoring activities with local and outside mentors. This includes immediate planning for an ROI application for each Junior Investigator. 3. Conduct strategic planning to maximize synergy in research and to give Junior Investigators a sense of ownership and shared goals and expectations. 4. Establish and maintain communication between mentors and Junior Investigators and among Junior Investigators in the COBRE, and foster development ofthe group into a functional team. 5. Establish a sustainable equipment core to support continued growth of the biomedical research enterprise at MSU. 6. Manage fiscal aspects of the COBRE in partnership with the Office of Sponsored Programs Administration and fiscal officers in the colleges and departments involved in the COBRE. Mentoring is a key responsibility of the Administrative Core, but a more detailed description of Aims 1 and 2, which focus on mentoring, is located in the Overall Description Section. This Administrative Core section focuses on Aims 3-6, which include more of the details of administrative structure and services provided to the investigators, which will allow us to accomplish the stated goals.